ENVIRONMENTAL AND MOLECULAR CARCINOGENESIS

PROJECT SUMMARY (See instructions): The Environmental and Molecular Carcinogenesis Program integrates 27 investigators (24 full members and 3 associate members) from several different departments on NYU campuses of Sterling Forest and the School of Medicine, sharing a common interest in understanding the Environmental causes of cancer. The overall goal of the Program is to understand the environmental etiology of cancer and to use this information for cancer prevention and early detection. The EMC Research Program focuses on the following goals: (1) Identifying the mechanisms of action for environmental carcinogens, with a strong focus on inorganic compounds, such as arsenic, nickel, chromium, and cadmium by investigating their effects on the structure and function of cellular macromolecules; (2) The formation of reactive oxygen species, their biochemistry, and the biological effects that might result from their cellular interactions; (3) The mutational specificity of carcinogens and the site-specific mutagenesis of particular DNA lesions, the molecular basis for genetic susceptibility to environmental agents, the effects of hormones on gene expression, carcinogenesis, and chemoprevention; and (4) Epigenetic mechanisms of carcinogenesis. To achieve these goals, research in this Program is divided thematically into four groups: 1) DNA adducts, DNA Damage and Repair; 2) Carcinogenesis and Animal Models; 3) Early Detection and Chemoprevention; and 4) Cell Signaling and Epigenetic Mechanisms of Carcinogenesis. Drs. Max Costa and William Rom are the Co-Leaders for this Program. Total funding decreased from $17,628,704 to $7,570,910 since the last competitive application. Membership has decreased from 47 to 28. Publications for the period total 323, of which 17% are intraprogrammatic, 16.1% are inter-programmatic, and 4% are both intra- and inter-programmatic collaborations

Public health relevance
. RELEVANCE (See instructions): The Environmental and Molecular Carcinogenesis Program integrates investigators whose research aims to understand the environmental etiology of cancer and to use this information for cancer prevention and early detection, with the ultimate goal of reducing the risk of cancer occurrence and death and improving the quality of life of cancer survivors.